Development of a highly-sensitive urine test for tuberculosis (TB) that detects diverse forms of urinary TB lipoarabinomannan (uLAM)

PROJECT ABSTRACT
Tuberculosis (TB) remains a major world-wide health problem and the development of a
sensitive point-of-care (POC) diagnostic for active TB infection is a global public health priority.
Lateral flow (LF) assays based on the detection of mycobacterial lipoarabinomannan (LAM)
antigen in patient urines are potential POC tests for TB, but current assays have suboptimal
sensitivity, and are not suitable for all populations. An early form of this assay, the Alere
Determine™ TB LAM Ag test, was strongly recommended by the WHO for diagnosis of active
TB in HIV-positive patients with a CD4 cell count of <200 cells/mm and advanced HIV disease.
A newer assay (the Fujifilm SILVAMP TB LAM assay) based on novel monoclonal antibodies
(mAbs) isolated or characterized in my lab was found to be considerably more sensitive for both
HIV-positive and HIV-negative populations, but still did meet the WHO’s Target Product Profile
for wide-spread utility. The FujiLAM assay utilizes a unique combination of a mAb (S4-20) that
is highly specific for M.tb LAM and a second mAb (A194-01) that is widely reactive with LAM
from many mycobacterial species. More recent studies in my lab using a standard panel of 25
large-scale urine samples collected from Ugandan patients preselected for a range of HIV
clinical status, CD4 cell count and LAM urinary concentrations have identified profound
differences in the immunochemical properties between ManLAM and uLAM, and have shown
significant diversity in the immunoreactivity of uLAM present in different patient urine samples.
These studies have included a novel combination of mAbs (FDX01/A194-01) that possesses
increased sensitivity and breadth of detection of uLAM in our standard urine panel, but may have
lower specificity for M.tb. All of the mAbs described above were isolated using ManLAM antigen
purified from cultured M.tb. Based on these results we now propose to characterize antigenic
diversity of uLAM across a range of TB phenotypes, including pulmonary and extrapulmonary TB,
HIV+ and HIV- TB, and determine the specificity of these different forms for TB against other
respiratory diseases, latent TB, and TB-uninfected cohorts. In parallel we will isolate mAbs that are
highly sensitive and specific for different forms of uLAM by B cell sorting and antibody cloning. We
will then select and validate the highest performing mAb combinations for TB disease detection
across a large panel of diverse TB and non-TB clinical samples, and compare their sensitivity and
specificity with that ofthe novel FDX01/A194-01 assay. These studies will address the hypotheses
that different LAM immunotypes detected in patient urines reflect important bacteriological and
host features integral to a generalizable diagnostic test, and that exploiting these forms will lead
to the enhanced detection of uLAM that will improve the sensitivity and specificity of urine assays
for detection of active TB infection.

Public health relevance
Narrative The immunodetection in the urine of patients of forms of the TB biomarker, lipoarabinomannan (uLAM), has shown promise as an inexpensive point-of-care (POC) assay for the diagnosis of active TB infections, but current reagents and assays do not have the required sensitivities or specificities needed for a widely useful assay. We have developed new insights into the nature of the urinary forms of LAM and have identified new antibodies and antibody combinations which may increase the sensitivity of these assays. The aims of this study are to test the utility of the currently available reagents and assays against large clinical panels, to understand the biological significance of the various LAM immunotypes present in different patient samples, and to isolate and test novel reagents that possess improved affinities and specificities for uLAM, which can be developed into a universal POC assay for active TB infections.